Opto-Electrical Cochlear Implants

Project Summary / Abstract
Our goal is to develop an optical cochlear implant (oCI) that uses photons to stimulate surviving auditory
neurons in severely-to-profoundly deaf. The benefit of optical stimulation is its spatial selectivity with the
potential to create significantly more independent channels to encode acoustic information and to enhance the
CI users’ performance in challenging listening environments and to improve music appreciation. In previous
experiments we have defined the parameter space for infrared neural stimulation (INS) in diverse animal
models, including the cat. To translate the method into a clinical tool, an opto-electrical cochlear implant, we
have to convert the parameter space defined for the cats to the larger cochlea of the humans. In preparation of
the study we have communicated with the Food and Drug Administration (FDA) and have submitted a Q-
submission for a study risk assessment for the first set of the proposed tests. The purpose of this study is to
show that optical and combined opto-electrical stimulation is possible in humans using optical fibers, optical
fiber bundles, and a hybrid opto-electrical cochlear implant. Furthermore, the tests will also validate that INS is
possible at radiation wavelengths, which are used commercially in communication and for which the
technology of optical sources and waveguides is well miniaturized and matured. Most importantly, we will use a
forward masking method to validate the view that optical stimulation is spatially more selective than electrical
stimulation by comparing the ability of a masking stimulus to reduce the response amplitude of a probe
stimulus. Test subjects will be patients with large tumors of the skull base, who require a translabyrinthine
craniotomy for tumor removal. For this surgical approach the cochlea and vestibular system will be damaged
and the patients will be deaf after surgery. This surgery provides an unique opportunity to test optical
stimulation in the human cochlea before it is removed during the tumor resection. Important data can be
gathered, which will drive the development of an implantable opto-electrical cochlear implant system by our
industrial collaborators. The measurements will take no longer than 30 minutes per patient, after which all the
equipment will be removed from the surgical filed and the tumor resection surgery continues.

Public health relevance
Project Narrative It has been shown that neural stimulation with infrared radiation is more spatially selective than electrical stimulation and could result in more independent channels to encode acoustic information in cochlear implants. Psychophysics experiments have shown that more independent channels available for encoding acoustic information will result in better music appreciation and performance of cochlear implant users in noisy listening environments, or during the use of tonal languages. While the parameters for infrared neural stimulation have been established in animal models, the proposed experiments are to translate the results into the clinic by validating the results in humans in acute tests during a translabyrinthine tumor resection surgery and to fabricate and test an first prototype of an optical cochlear implant.